Phase I trial of Endoxifen Gel Versus Placebo Gel in Women Undergoing Breast Surgery

The proposed clinical trial will address whether daily application of endoxifene gel in escalating dose cohorts is tolerable and safe compared to placebo gel.